Placental Serum Amyloid A as a Therapeutic Target to Prevent Preterm Birth and Prematurity Related Morbidity

Summary
Preterm birth (PTB) and associated fetal brain injury bring about adverse perinatal outcomes including
mortality in offspring, and high cost of care and treatment for the family and society. The pathologic immune
responses in the placenta during maternal inflammation (MI) are thought to be the major causes of PTB and
perinatal sequelae. Yet, the mechanisms are still not well understood because of the complexity of placental
structure and function. Towards that end, there is a paucity of therapeutic agents capable of protecting
offspring from exposure to MI. Serum amyloid A (SAA) has been identified as an inflammatory biomarker and
its pathologic role has not been studied in the context of MI. Our published data demonstrated that one
isoform, SAA2 was absent from the development in the placenta but highly susceptible to acute maternal
inflammation. In this proposal, we plan to investigate the role of placental SAA isoforms in response to sub-
chronic MI and explore whether inhibition of Saa2 systemically using small interfering RNA (siRNA) alleviates
PTB and adverse offspring outcomes (Aim 1). Furthermore, we will compare the effect that whether
administration of siRNA to Saa2 via targeted-placenta infusion will have higher efficacy and safety than via
systemically infusion following sub-chronic maternal inflammation (Aim 2).The project will have a significant
impact on the field of maternal-fetal medicine as it will provide placental SAA2 as a potential therapeutic target
and will demonstrate a novel targeted-delivery route of siRNA to the placenta for the treatment of MI induced
PTB and associated fetal brain injury.

Public health relevance
Narrative This exploratory study aims to evaluate serum amyloid A 2 as a novel placental candidate for the prevention of maternal inflammation-induced preterm birth and adverse fetal outcomes. Filling gaps in the field of placenta- targeted RNAi therapy, this high-risk high reward proposal aims to arrive at a new therapeutic strategy to decrease preterm birth and its adverse perinatal sequelae. This preclinical study opens a significant translational avenue to promote the recovery of reproductive diseases.